Dissecting the neural substrates of interhemispheric integration in the larval Drosophila olfactory system

Project Summary
All animals with bilateral symmetry must integrate the sensory input from the left and right sides of their
bodies in order to make coherent perceptual decisions. A wide range of neurological and psychiatric disorders
have been associated with reduced structural and functional connectivity between the two cerebral
hemispheres. However, the detailed causes and effects of this impaired connectivity remain obscure in many
cases. Efforts to unravel the neurophysiological mechanisms of interhemispheric integration (IHI) in mammals
have been hindered by the overwhelming numerical complexity of the mammalian brain and the lack of
sufficiently precise tools for dissecting the underlying neural circuits. I propose to take a novel, reductionist
approach to this problem by leveraging the experimental accessibility of the larval Drosophila brain to dissect
the circuit basis for IHI in the context of olfactory sensory processing. The Drosophila larva is the ideal system
in which to approach this problem owing to the small size of its brain (just ~10,000 neurons), the optical
transparency of its body, and the availability of numerous genetic tools for manipulating individual cells and cell
types. Furthermore, the overall glomerular architecture of the larva’s olfactory system bears a striking
resemblance to that of the mammalian olfactory system: sensory signals originating from the left and right
sides of the head are kept largely separate until reaching a higher-order brain center called the mushroom
body (MB), where various bilaterally projecting cell types seem to pool input from the two sides of the animal.
However, despite a flurry of recent progress in understanding the MB circuit, to date there has not been any
concerted attempt to dissect the substrate of IHI in this system. The first aim of my project is to identify the
processing layer at which unilateral odor responses are transformed into bilateral stimulus representations.
The second aim is to characterize the behavioral manifestation of IHI by unilaterally ablating various cell types
in the larval olfactory system and assaying for impairments to chemotaxis. My third aim, inspired by the
phenomenon of bistable olfactory perception in humans, is to characterize the circuit and behavioral response
to the presentation of conflicting stimuli to the left and right sides of the animal simultaneously. This work,
which leverages the Samuel lab’s expertise in functional imaging and behavioral analysis, will begin to address
the mechanism by which the brain integrates bilateral sensory stimuli to form a unified internal model of the
world. Elucidating the emergence of perceptual unity is a key aspect of my long-term research interests and
promises to yield basic conceptual insights bearing on the etiology of many human brain disorders.

Public health relevance
Project Narrative Integration of sensory information from the left and right sides of the body underlies our ability to respond coherently to environmental cues; however, its physiological basis remains poorly understood. Using the larval fruit fly olfactory system as an experimental model, my project aims to discover general principles governing the emergence of perceptual unity from parallel input streams. This knowledge will provide a conceptual foundation for understanding how impaired interhemispheric integration contributes to and results from numerous brain disorders.